Dissecting host-virus interactions underlying motor neuron toxicity in Acute Flaccid Myelitis

Project Summary
Acute flaccid myelitis (AFM) is a debilitating polio-like paralytic illness of children caused by enterovirus
infection. There have been several international outbreaks of AFM in the past decade associated with
Enterovirus D68 (EV-D68) and Enterovirus A71 (EV-A71), representing a significant public health threat. AFM
is characterized by viral invasion of the spinal cord with subsequent infection of motor neurons followed by
their dysfunction and death, however the mechanisms leading to motor neuron injury are not known.
Interestingly, EV-A71 is associated with a spontaneously reversible form of AFM, whereas the paralysis
resulting from EV-D68 infection is typically permanent. We will therefore leverage this clinical observation to
identify which EV-D68 gene or genes are responsible for irreversible paralysis via motor neuron toxicity, and
identify perturbed host neuronal functions that lead to cell death. We hypothesize that the EV-D68 2A protease
(2Apro) promotes the death in motor neurons via mechanisms that include NPC dysfunction and Wallerian
degeneration, and that these processes are effective targets for therapeutic intervention. Our preliminary data
in induced pluripotent stem cell (iPSC)-derived motor neurons show increased toxicity of EV-D68 vs EV-A71
and demonstrate evidence of nuclear pore complex (NPC) dysfunction and Wallerian degeneration in EV-D68-
infected neurons. Our first aim is to identify viral factors causing differential motor neuron toxicity of
Enterovirus D68 vs Enterovirus A71. Our second aim is to determine the extent of persistent Nuclear Pore
Complex dysfunction in motor neurons after EV-D68 infection and evaluate approaches for Nuclear Pore
Complex repair. Our third aim is to define the role of Wallerian degeneration in EV-D68-induced motor neuron
dysfunction and death. We will achieve these aims via complementary in vitro and in vivo approaches using
human iPSC-derived motor neurons, and a well-established mouse model of AFM via intramuscular injection of
enteroviruses. At the conclusion of the study, we will also identify strategies for NPC repair and novel
regulatory pathways of NPC biogenesis, reveal a role for Wallerian degeneration in neuroinfectious disease,
and establish a rationale for neuroprotective therapies in AFM.

Public health relevance
Project Narrative Acute flaccid myelitis (AFM) is a polio-like disorder of children due to the infection of spinal motor neurons by enteroviruses, most commonly Enterovirus D68 (EV-D68) or Enterovirus A71 (EV-A71). The proposed project will leverage differences in the toxicity of EV-D68 and EV-A71 to identify which EV-D68 gene(s) are responsible for its enhanced neurotoxicity, determine the role of nuclear pore complex dysfunction in toxicity, evaluate the role of Wallerian degeneration in pathogenesis, and evaluate nuclear pore complex repair and inhibition of Wallerian degeneration as therapeutic strategies. The outcome will be to elucidate the mechanisms of neurotoxicity underlying AFM, develop a rationale for neuroprotective therapies, and evaluate specific therapeutic targets.